Relationships With Adult Children & Cognitive Func - Resubmission (Change of Recipient Organization)

Relationships with Adult Children and Cognitive Functioning across Social Groups and Nations
Project Summary/Abstract
Uncovering processes that may slow cognitive decline is a key research goal identified in the National Plan to
Address Alzheimer’s Disease. Studies show that social integration and support predict slower cognitive
decline. However, few studies have investigated how specific types and characteristics of social relationships
are related to cognitive health. Adult children are a highly salient source of social support to aging adults that is
growing in importance as life spans lengthen. Older adults with close ties to and frequent contacts with adult
children may have better access to the emotional, material, and health-related support that helps stem
cognitive decline. Frequent interaction with adult children may also provide stimulation that helps maintain
cognitive functioning organically. Yet, the meanings of parent-child relationships vary across race, class, and
gender, and aspects of relationships with adult children that support cognition may be especially beneficial to
some vulnerable groups. The relationship between ties to adult children and cognition may also depend on
national context, and be particularly important in countries that rely on families to provide elder care.
This project intends to expand knowledge about how relationships with adult children are related to
cognition in hopes of locating aspects of these relationships that may help to slow cognitive decline.
Specifically, it will use longitudinal data from the Health and Retirement Study (HRS) and the National Social
Life, Health, and Aging Project (NSHAP) to examine how perceptions of support and strain from, the presence
of confiding ties to, frequency of contact with, and coresidence with adult children among U.S. adults age 50+
are related to cognitive functioning over the following ten years (Specific Aim 1). These analyses investigate
the hypothesis that older persons with close relationships to one or more adult child will have slower rates of
cognitive decline than parents who do not and childless peers. The second part of the study will assess race,
class and gender differences in these relationships (Specific Aim 2). The findings may contribute to
explanations for disparities in cognition among these groups, as well as reveal mechanisms through which they
might be addressed. The third and last part of the project will explore whether relationships between the
presence of confiding ties to, frequency of contact with, and coresidence with adult children and cognition differ
between older adults in the U.S. and Europe using the Survey of Health, Aging and Retirement in Europe
(SHARE; Specific Aim 3). Findings of this aim will highlight specific national contexts under which close ties to
adult children may benefit cognition most. The analysis of these secondary data sources will be carried out
using multilevel growth curve models (for the HRS and SHARE) and cross-lagged panel models (for NSHAP
and SHARE). Analyses of NSHAP and SHARE will also use inverse probability weighting to help account for
selection processes. Combining the three aims, this project will generate needed insights about whether and
under what circumstances parent-child relationships protect cognitive health.

Public health relevance
Relationships with Adult Children and Cognitive Functioning across Social Groups and Nations Project Narrative This project will utilize longitudinal data from the Health and Retirement Study, the National Social Life, Health, and Aging Project, and the Survey of Health, Aging, and Retirement in Europe to assess how characteristics of older adults’ social relationships with adult children—including relationship support and strain, perceptions that they can confide in them, how emotionally close they feel to them, whether they live with them, and how frequently they interact with them—are related to their cognitive functioning over time, with childless older adults as a comparison. It will also assess whether these relationships differ by gender, socioeconomic status and racial/ethnic background, and between the U.S. and Europe. The objective is to identify aspects of relationships between older parents and adult children that may benefit cognitive functioning and slow the progression of Alzheimer’s disease and related disorders, contributing to public health efforts to improve the health of aging populations, including the National Plan to Address Alzheimer’s Disease.